Translational Research Training in Hepatology

Summary/Abstract: This application to establish a postdoctoral T32 training program in Translational Research
in Hepatology to be administered at the University of Southern California (USC) Keck School of Medicine in
conjunction with the Children's Hospital Los Angeles (CHLA), with affiliations at the USC Schaeffer Center for
Health Policy and Economics. This training program leverages substantial university and department level
investments in research infrastructure and faculty recruits, a steady rise in the quality of the training-grant-eligible
applicant pool and the rich diversity of patient populations in Los Angeles to provide a robust research training
experience. This Program is focused on training physician-scientists who are accepted to USC/CHLA
Gastroenterology fellowships and will provide up to 3 years of support for intensive laboratory or clinical research
training and mentored research for 10 MD (or MD/PhD) trainees over five years. Trainees will conduct laboratory,
clinical and/or translational research (T1-T4 spectrum) under the mentorship of 16 highly qualified research
mentors who have a solid track record of NIH (NIDDK) funding and exceptional mentoring accomplishments.
Research themes of (i) Hepatic Immunology, Injury and Regeneration; (ii) Hepatic Steatosis and Fibrosis; and
(iii) Clinical Outcomes and Community/Healthcare Implementation reflect the research strengths and training
opportunities within well-established research collaborations at USC/CHLA. An individualized curriculum will
focus on building each trainee’s research knowledge base, critical investigative abilities and technical skills, with
diligent oversight of the training progress by primary mentors, as well as mentoring and executive committees.
The institutional environment at USC/CHLA and affiliates provides abundant resources (research institutes and
centers with a wide range of cores), a rich intellectual milieu for training in digestive diseases research including
masters’ level training in clinical research methods, and dedicated trainee-mentor activities including an annual
fellow-led symposium, biweekly work-in-progress meetings, and monthly journal clubs. Further, this training
program occurs in the multi-ethic environment of Los Angeles, providing a unique educational opportunity to
study liver diseases in minority populations. The ultimate goal of this T32 Training Program is to prepare GI
trainees to assume a faculty-level position and compete successfully for independent research funding across
the spectrum of translational liver diseases research to address the significant burden of liver disorders in the
U.S. and globally.

Public health relevance
Project Narrative: Acute and chronic liver diseases contribute to substantial morbidity, mortality and healthcare costs, and research to understand, diagnosis, prevent and treat liver conditions is critically important to improve human health. This postdoctoral training program for adult and pediatric gastroenterology fellows (MD or MD/PhD) will provide basic-translational or clinical-translational training pathways in hepatology research with rigorous training and robust mentorship in support of the next generation of physician–scientists.